NBER Center for Aging and Health Research - Au Suppl -- Framingham Heart Study

OTHER PROJECT INFORMATION – Project Summary/Abstract
The COVID-19 pandemic profoundly impacted both clinical and non-clinical care of people living with dementia.
This project establishes a new research collaboration between the NBER Center and the Framingham Heart
Study Brain Aging Project (FHS-BAP) at Boston University, and through that collaboration, studies The Effects
of COVID-19 on Clinical Care of People with Alzheimer’s Disease. The parent grant, NBER Center for Aging
and Health Research, integrates into a unified programmatic structure a larger collection of NBER research
activities on health at older ages, as well as incubating new research networks on related issues. While the
parent grant is not focused on Alzheimer’s Disease, the supplement adds an important clinical dimension to the
Center’s other developmental research activities on ADRD and, importantly, facilitates broader researcher
access to a rich new data resource that links data from the Framingham Heart Study Brain Aging Project with
Medicare claims. The proposed analytic work adds COVID-19 infection, symptoms, and other related measures
to existing economic models for health care utilization and costs; identifies patients with COVID-19 onset in
Framingham Heart Study C4R data; and uses the data to characterize patterns of health care utilization and
costs for AD and for AD-related co-morbid diseases/risk factors – before and through the course of the COVID-
19 pandemic. The project also builds a new linked data infrastructure that combines FHS, CMS, and other data;
facilitates wider use of these data; and creates new opportunities for collaborative work between economics
researchers and biomedical researchers in studying the dynamics of the COVID-19 pandemic, clinical care for
people living with dementia, and health outcomes.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The COVID-19 pandemic profoundly impacted the medical care ecosystem, as it accommodated the direct care of people with COVID-19 infections, and as many other categories of care were deferred or foregone. Using a rich new linked data infrastructure, built from the Framingham Heart Study, this project characterizes patterns of health care utilization and costs for Alzheimer's Disease and other dementia-related conditions before and through the course of the COVID-19 pandemic.